Isolating and mitigating sequentially dependent perceptual errors in clinical visual search

Project Summary
When looking at an x-ray, radiologists are typically asked to localize a tumor (if present), and to
classify it, judging its size, class, position and so on. Importantly, during this task, radiologists
examine on a daily basis hundreds and hundreds of x-rays, seeing several images one after the
other. A main underlying assumption of this task is that radiologists’ percepts and decisions on a
current X-ray are completely independent of prior events. Recent results showed that this is not true:
our perception and decisions are strongly biased by our past visual experience. Although serial
dependencies were proposed to be a purposeful mechanism to achieve perceptual stability of our
otherwise noisy visual input, serial dependencies play a crucial and deleterious role in the everyday
task performed by radiologists. For example, an x-ray containing a tumor can be classified as benign
depending on the content of the previously seen x-ray. Given the importance and the impact of serial
dependencies in clinical tasks, in this proposal, we plan to (1) establish, (2) identify and (3) mitigate
the conditions under which serial effects determine our percepts and decisions in tumor search tasks.
In Aim 1, we will establish the presence of serial effects in four different clinically relevant domains:
tumor detection, tumor classification, tumor position and recognition speed. In Aim 2, we plan to
identify the specific boundary conditions under which visual serial dependence impacts tumor search
in radiology. In Aim 3, once we will fully understand these boundary conditions in Aim 2, we will
propose a series of task and stimulus manipulations to control and mitigate the deleterious effects of
visual serial dependence on tumor search. As a result of these manipulations, visual search
performance should improve in measurable ways (detection, classification, position, speed). Aim 3 is
particularly crucial because it will allow us to propose new guidelines which will greatly improve tumor
recognition in x-ray images, making this task even more effective and reliable. Taken together, the
proposed studies in Aim 1, 2, and 3 will allow us to establish, identify, and mitigate the deleterious
effect of serial dependencies in radiological search tasks, which could have a significant impact on
the health and well-being of patients everywhere.
!
!
!

Public health relevance
Project Narrative Our proposal is designed to investigate the detrimental impact of visual serial dependencies in clinical settings. Serial dependencies significantly impact our perceptual experience, but little is known about their detrimental consequences when radiologists are asked to detect tumors in x-rays. Crucially, the final goal of our research project is to develop recommendations and guidelines to mitigate the negative effect of serial effects and, thus, improve diagnosis accuracy.